Path A - Advancing Iowa's Efforts in Continuing to Attain High Rates of Compliance with the FDA's Produce Safety Rule through Education, Outreach & Technical Assistance to Iowa Growers

Iowa (IA) Path A: Project Summary/Abstract
Advancing Iowa's Efforts in Continuing to Attain High Rates of Compliance with
the FDA's Produce Safety Rule through Education, Outreach & Technical
Assistance to Iowa Growers
In March 2021 the Iowa Department of Agriculture and Land Stewardship (IDALS) was made
aware of the FDA FOA# PAR-21-174. Continuing and strengthening work conducted under
PAR-16-167, IDALS convened its Produce Safety Rule steering committee and began
development of a five-year project plant to advance compliance with the FDA’s Produce Safety
Rule with Iowa’s fruit and vegetable growers. As with PAR-16-137, the state will continue to
conduct program objectives aligned with outreach, education, and technical assistance as well
as farm inventory development as outlined in Path A of PAR-21-174. With support of its
partners, the Iowa Department of Agricultural and Land Stewardship’s new five-year program
will align with the four objectives as outlined in the program announcement for Path A. While
the program will continue the overall goal to enhance production of safe produce, the program
will advance this aim by using and amending a living project plan as well as a written
assessment of Iowa’s produce farms to be submitted at the end of Year 1. The living project
plan has been initiated and is submitted in its first iteration with this funding opportunity
submission by IDALS. These documents will capture the program’s administrative capacities,
provisions for educational opportunities, outreach strategies, technical assistance offerings, and
the management of the state’s farm inventory.
A further emphasis will be on the continuance of a building strong partnerships with the sub-
awardee, Produce Safety Rule colleagues at other state programs, FDA personnel, and NASDA
– as well as state stakeholders via a proposed Produce Safety Stakeholder Advisory Board.
Farm inventory verification and updating is emphasized along with outreach, training, and
technical support strategies.

Public health relevance
Iowa (IA) Path A PAR-21-174 Program Narrative The State of Iowa Program will follow the Program Path A with a focus on Program Objectives 1, 2, 3, and 4 as outlined in the funding opportunity PAR-21-174. The state program mission is to strengthen and enhance the existing structures in place that establish knowledge and adherence to the FDA Standards for the Growing, Harvesting, Packing, and Holding of Produce for Human Consumption, otherwise known as the Produce Safety Rule under 21 CFR Part112.